Within-person prediction of differential responding to perseverative thought disengagement strategies

Project Summary/Abstract
Perseverative (repetitive) thought, an umbrella term that encapsulates thoughts such as worry and rumination,
is a major transdiagnostic symptom and mechanism of internalizing psychopathology. Perseverative thought
varies in expression both between- and within-person; for example, in terms of its uncontrollability, valence, and
abstractness. Although the uncontrollability of perseverative thought explains most of the variance in its
relationship to adverse mental health outcomes, other features (e.g., valence, abstractness) have also been
identified as maladaptive. Strategies for regulating perseverative episodes typically operate on one or more of
these features; for example, aiming to increase concreteness or positive valence. Notably, there is little empirical
guidance to suggest which kinds of strategies should be used given a particular set of thought features. Instead,
“matching” decisions (which strategy to implement for which thoughts) are typically grounded in clinical
experience or individual trial-and-error. In line with the NIMH Strategic Plan Objective 3.2, we will apply principles
of precision medicine (“what works for whom?”) at the within-person level (“what works and when?”). Specifically,
we will leverage mobile digital technologies and quantitative methods such as machine learning to test as well
as generate within-person predictions regarding the efficacy of four evidence-based regulatory strategies
(cognitive reappraisal; focused attention meditation; savoring; absorption practice) as a function of the features
of the thought being regulated (negative valence; abstractness; verbal vs visual properties; temporal orientation;
passiveness). Participants will be 200 community-dwelling adults who report elevated perseverative thought. In
an ecological momentary intervention design, participants will be signaled four times per day for 20 days (80
signals total) to: 1) rate their current mood, impairment, and thought features; 2) complete one of the four active
strategies or a self-monitoring control (counterbalanced; within-person design); and 3) re-rate their mood,
impairment, and selected thought features. We will test several theory-driven hypotheses regarding differential
immediate (same signal) and sustained (next signal) efficacy of thought strategy as a function of momentary
thought features (rated pre-strategy). We will also use machine learning to examine the extent to which we can
predict the efficacy of a particular strategy from thought feature ratings obtained immediately prior to completing
the strategy. Finally, we will conduct preliminary exploratory analyses probing potential moderators at the
between-person level. Findings from this work will have direct clinical utility and relevance for theoretical models
of perseverative thought. This work will also provide a necessary foundation for the development of personalized
just-in-time adaptive interventions that can tailor strategy recommendations on an individual basis in real-time.

Public health relevance
Project Narrative Whereas psychotherapeutic interventions for perseverative thought (e.g., worry; rumination) have historically been limited in time and place (e.g., one hour per week at a therapist’s office), mobile interventions offer the opportunity to provide real-time support when and where the patient needs it most. The present study will leverage experimental, ecological momentary, and quantitative methods to test within-person predictions about the differential efficacy of four momentary regulatory strategies (cognitive reappraisal; focused attention meditation; savoring; absorption) as a function of the thought being regulated (i.e., the valence, abstractness, verbal-linguistic quality, temporal orientation, and passiveness of the thought). Beyond its immediate clinical utility, this work will establish a foundation for the development of just-in-time adaptive interventions that “learn” over time which strategies are most likely to be helpful for a given individual in regulating a perseverative episode with a given set of features, and tailor strategy recommendations in real time.